Transcription Factors Overcoming Chromatin Barriers to Control Cell Fate

Project summary:
The goal of this proposal is to reveal mechanisms by which gene regulatory proteins overcome chromosome
structural barriers, to change cell fates. The work will provide foundational insight into gene regulation and more
efficient ways to generate new cell types for therapy and disease modeling. The proposal extends from 38 years
of research on my R01 grant, to dissect the interplay between pioneer transcription factors and initially targeted
chromatin, combined with new directions from my recently expired P01 grant, where we revealed the functional
complexity of mammalian heterochromatin states. Work on both grants revealed that after the initial closed
chromatin binding by pioneer factors, a rate-limiting step of cell reprogramming is the inefficiency of activating
genes in H3K9me3 heterochromatin. We defined pioneer transcription factors by their ability to target a DNA
motif, or a partial motif, on a nucleosome, and thereby initiate cooperative events in DNase/ATAC-resistant,
transcriptionally silent chromatin bound by linker histone. Yet despite the ability to target linker histone-
compacted chromatin in vitro and in vivo, we and others found that some, but not all, pioneer factors are impeded
from binding H3K9me3 heterochromatin, leading us to investigate how certain pioneer factors can target such
heterochromatin. In the past grant period, our biochemical, structural, single molecule tracking, genomic, and
long-read sequencing approaches revealed that pioneer factors interact with core histones to facilitate
nucleosome binding and chromatin opening, that pioneer factors use unstructured domains for opening and
linker histone displacement, and that a pioneer factor licenses a nucleosome remodeler to further open local
chromatin. Having genetically identified amino acids on pioneer factors for binding nucleosomes, not free DNA,
in vitro allows us to assess, in vivo, truly pioneering events by the factors. We discovered diverse proteins
functionally bound to heterochromatin that repress genes and DNA repeats and are associated with varying
H3K9me3 and H3K27me3 marks, thereby defining heterochromatin subtypes. We propose to categorize pioneer
factors by the subtypes of heterochromatin that they target. We will use transcription factor binding to in vitro
heterochromatin reconstituted on nucleosome arrays, pulldowns between transcription factors and biochemically
fractionated heterochromatin, and genetic approaches in mice and cell cultures to define protein domains on
pioneer factors that enable heterochromatin subtype targeting and local chromatin opening, and that can be
transferred to other proteins to enhance reprogramming. We will use our dual-degron technology and knock-
downs to reveal how mammalian H3K9me3 heterochromatic domains are established and can be disassembled
selectively, to enhance reprogramming. We will determine the basis for, and utility of, our discovery of a transient
global disruption of heterochromatin elicited by reprogramming pioneer factors. The work will be performed in a
research environment that promotes diversity, equity, and inclusion. Our approaches will reveal basic genetic
mechanisms and will be applied to improving directed cell fate changes for biomedical purposes.

Public health relevance
Project Narrative: Of the many examples of cellular trans-differentiation and reprogramming in the research literature, very few if any efficiently generate new cells that exhibit terminal differentiation suitable for cellular therapeutics and disease modeling. In the past funding periods of my two grants that converge into this R35 application, our laboratory has found that genes residing in particular varieties of chromosomal condensation, known as H3K9me3-heterochromatin, are refractory to activation during trans-differentiation and reprogramming. The present application uses a research environment for diversity, equity, and inclusion to bring together diverse technologies and cellular systems to understand how gene regulatory proteins overcome the heterochromatin barrier and to apply the information to create more differentiated cells for therapeutics and disease modeling.